Produce Safety Alliance

Project Summary/Abstract
Ensuring the availability of safe fruits and vegetables for all consumers is the broad,
long-term goal of this project. This supports the FDA mission of protecting public health
and ensuring the safety of our nation's food supply. To achieve this goal, the Produce
Safety Alliance (PSA) team will continue to expand its training, education, outreach, and
technical assistance efforts to all those involved in keeping produce safe from farm to
fork. This will be done by seeking input from all sectors of the produce industry to
identify gaps in knowledge as well as challenges to implementation of food safety
practices. We will maintain and expand our collaborative networks regionally, nationally,
and internationally to share produce safety information and build inclusive programming.
We will gather relevant research data on the most effective ways to reduce microbial
risks so that the new educational materials and training programs the PSA team
develops to fill knowledge gaps and overcome challenges are science-based and
accurate. The PSA team will keep all of the curricula updated as Food Safety
Modernization Act (FSMA) Produce Safety Rule (PSR) subparts are modified and
guidance is finalized. In addition, we will coordinate additional translations of the PSA
Grower Training Curriculum and adjust delivery policies to expand training options to
meet the literacy level and language needs of growers. The PSA team will continue to
expand the cadre of PSA Trainers to make certain that no matter where produce
industry personnel are located, they will have access to high quality trainers capable of
effectively delivering training programs and answering questions about the FSMA PSR.
The PSA will collect and analyze PSA training evaluations from registered courses to
monitor program effectiveness and address any problems that are identified. We will
continue to support PSA Trainers with monthly educators' calls to increase their food
safety knowledge and an annual webinar to share new or revised PSA policies and
FSMA PSR updates. We will continue monthly updates with our PSA Executive
Committee and quarterly updates with our PSA Steering Committee. As new challenges
arise, we will be prepared to facilitate discussions and host special topic summits to
increase dialogue between all stakeholders. Lastly, the PSA team will collect, maintain,
and organize all resources into an easily accessible repository that is frequently updated
to build user trust in the value of the information.

Public health relevance
Project Narrative The purpose of the Produce Safety Alliance is to help ensure the safety of fresh fruits and vegetables by providing training, educational materials, and technical assistance to those who grow, harvest, pack, handle, sell, and regulate fresh produce so they can implement practices to reduce microbial risks at every step in the production and distribution chain. The consumption of fresh fruits and vegetables is a critical part of maintaining public health by providing people with necessary nutrients that help to maintain proper body weight and reduce the risks of long-term negative health impacts such as obesity, diabetes, and cancer. Educating and training produce industry members, from farms to retail produce departments, will protect customers and reduce demand on the healthcare system by preventing produce-associated foodborne illnesses, ensure an abundant supply of fresh produce is available, and prevent economic losses caused by foodborne illness outbreaks.